Role of microRNAs in intestinal stem cell regulation and cancer initiation

? DESCRIPTION (provided by applicant): Wnt/ß-catenin signaling is crucial for maintenance and activation of intestinal stem cells (ISCs). Mutations resulting in unregulated Wnt/ß-catenin have been linked to tumor initiation and growth. Recent evidence suggests that this pathway may also be a key mediator of the transition of ISCs to cancer stem cells (CSCs), which exhibit stem like features and contribute to metastasis and resistance to treatment. The underlying mechanisms by which canonical Wnt signaling mediates tumor formation are largely unknown, but emerging evidence suggests that deletion of APC or stabilization of ß-catenin results in aberrant expression of microRNAs (miRNAs). MiRNAs, a diverse class of highly conserved small non-coding RNAs (~22 nucleotides long), have been shown to play a critical role in cellular homeostasis and development and may also contribute to carcinogenesis. Whether miRNAs directly mediate the transformation of Lgr5+ ISCs has not been explored. To investigate the role of miRNAs in Wnt-mediated tumor formation, we performed global profiling of miRNA expression from intestinal crypts following stabilization of ß-catenin. Our analysis identified five miRNAs (let- 7e, miR-96, miR-223, miR-411 and miR-423-5p) that were differentially expressed and identified a general trend towards down-regulation of miRNAs, a phenomenon observed in human cancers. The following specific aims are designed to further investigate the role of miRNAs in the regulation of intestinal stem cells and the initiation of cancer. Aim 1. To investigate the role of specific miRNAs, identified by global crypt profiling, on ISC behavior. Aim 2. To determine the impact of global miRNA down-regulation on ISC behavior and adenoma formation. In summary, this proposal seeks to delineate the role of miRNAs and their targets on ISC behavior and adenoma formation. We anticipate that this could provide the basis for the development of novel Wnt-based biomarkers and therapeutics for intestinal cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this project is to identify microRNAs (miRNAs) that contribute to tumor initiation through modulation of their target messenger RNAs in intestinal stem cells. We will further characterize the molecular mechanisms by which these miRNAs function, particularly in the presence of mutations in the Wnt signaling pathway. Since, activation of the Wnt signaling pathway plays a predominant role in tumorigenesis, identification of these miRNA targets could provide the basis for the development of novel biomarkers and therapeutics for intestinal cancer.